Elucidating Chemical Signaling Mechanisms that Regulate Multicellularity and the Transmission of Infectious Disease

Project Summary / Abstract
Organisms rarely live in isolation. They live in complex multi-species communities where soluble chemical factors
mediate cell-cell signaling, cooperation, and competition. Mutualist microbes exchange metabolites and signals
to benefit their hosts in myriad ways, while parasites release virulence factors that harm their hosts. Microbes
also exhibit similar chemically mediated benefits and challenges to one another in environmental and host-
associated contexts. From a cellular perspective, even a multicellular organism can be considered a complex
symbiosis of phenotypically distinct cells using chemicals to cooperate for the overall benefit of the ‘community’.
My laboratory of chemists, biochemists, and biologists aims to discover the chemical languages that shape
interactions within microbial communities and between microbes and their hosts. Our proposed work focuses on
chemical signaling in three distinct areas. First, we aim to uncover chemical signaling processes that regulated
key transitions in the origin of the first multicellular animals (e.g., formation of multicellular bodies and
differentiation of cell types). We pursue this goal by identifying the chemical signals and mechanisms that
regulate multicellular behaviors in some of the closest living relatives of animals—the unicellular holozoans
Capsaspora owczarzaki, Ministeria vibrans, Salpingoeca rosetta, and Corallochytrium limacisporum. This work
may reveal how the first animals evolved and may inform how the diverse cells within healthy animals develop
and function. Second, we aim to uncover chemical signaling processes that enable the protozoan snail symbiont
Capsaspora owczarzaki to colonize its snail host. This symbiont can kill the parasitic schistosomes that mature
in snails before spreading to humans where they cause the neglected tropical disease schistosomiasis.
Therefore, understanding Capsaspora’s ability to persist in snails and hunt schistosomes may improve its
development as a biocontrol agent to curtail the spread of schistosomes through snails near human populations.
Finally, we aim to uncover new chemical signals that regulate bacterial behaviors necessary for pathogenesis.
By arresting these behaviors, we can disarm pathogens. Overall, our work will reveal previously unrecognized
ways that symbionts and cells within animals communicate and compete on a chemical level. This work may be
applied to reveal the most fundamental mechanisms of regulated multicellularity in animals, and it also may be
applied to inform efforts to curtail the transmission and virulence of infectious diseases.

Public health relevance
Project Narrative The proposed research aims to uncover information to help develop a new schistosomiasis control strategy and bacterial antivirulence strategies. The work also aims to determine which molecules are fundamentally required for the evolution of animal cellular adhesion and differentiation—important phenotypes for a range of diseases from immune disorders to cancer. Because this project is applicable both to curtailing microbial infections and to understanding some of the most common diseases in the U.S., it is relevant to human health and the NIH’s mission to reduce illness.